Molecular Mechanisms and Evolution of Phenotypic Plasticity

Phenotypic plasticity is used by an incredible diversity of organisms, from plants to humans. Its ubiquity attests
to its fundamental importance in life. This project addresses the fascinating and understudied question of the
mechanistic basis of phenotypic plasticity – i.e., how developmental processes are influenced by
environmental cues to cause phenotypic differences -- and, importantly, how those processes evolve. The
focus here is on an innovative model, the pea aphid, which exhibits a textbook example of phenotypic
plasticity. This species offers an unparalleled opportunity to examine the role of nature and nurture in
phenotype determination: it exhibits dramatically different winged and wingless morphs that are induced by
environmental conditions in genetically identical, asexual females and controlled by a single genetic locus in
males. Thus, strikingly, two dimorphisms, each under different control mechanisms, exist within this single
species. The proposed experiments build on the exciting recent discoveries made by the PI about the role of
hormones and horizontally transferred genes in the female wing plasticity and about the identification of the
wing polymorphism locus in males, which has an insertion containing a duplication of a gene that influences
signaling (follistatin) and which is specific to wingless males. The proposed, vigorous research program aims to
decipher the molecular mechanisms underlying the function and evolution of plasticity. Experiments on the
wing plasticity will examine the regulatory changes that control it, the epigenetic changes that accompany it,
and test if horizontally transferred genes are preferentially recruited into the process. Experiments on the
genetic male wing dimorphism will use functional and evolutionary studies of the follistatin paralogs to establish
how changes in these paralogs underlie male morphological evolution. Studies in females and males will be
united with experiments that will test whether or not the more recently derived male dimorphism evolved by
genetic accommodation of the female plasticity, hypothesizing that males bypass the environmental signals
used by the female plasticity. These studies will provide some of the first insights into the mechanistic basis of
genetic accommodation, where trait variation shifts from being caused by “nurture” to “nature”. These
experiments will have broad implications for understanding the mechanistic basis and evolution of plasticity,
which is significant from a human health perspective because of the numerous plastic traits that influence
human health and disease.

Public health relevance
Project Narrative Nearly all phenotypes, from height and weight to disease susceptibility, result from a complex interplay between genes and the environment. This project aims to illuminate basic rules acting to integrate environmental and genetic signals in the production of the phenotype. Thus, the proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help to reduce the prevalence of human disease.